Research Supplement to Promote Diversity Supplement for the ECMO without Anticoagulation

PROJECT SUMMARY/ABSTRACT
Nitric Oxide (NO) is a gaseous radical continuously produced by the endothelial nitric oxide
synthase (eNOS) enzyme within the walls of the blood vessels and is an essential molecule to
maintain homeostasis and prevent blood clot formation. NO is an extremely reactive molecule with
only 2 ms half-life and can form various metabolites in the blood. The artificial surfaces of blood
contacting devices can activate platelets and induce thrombus formation. This is a not desired
side effect of Extracorporeal Life Support (ECLS) circuits and is typically prevented by systemic
anticoagulation, which however increases the risk of hemorrhagic complications. Hence, there is an
effort to create more biocompatible artificial surfaces that obviate the need for systemic
anticoagulation.
NO emitting artificial surfaces offer attractive solution to this problem. However, the NO payload of
such surfaces is inherently limited.
In this research supplement we would like to explore an alternative approach, where the available
NO payload is circulating within the blood in the form of NO metabolites (e.g., nitrite, small and
large molecular weight S-nitroso thiols) as reservoirs and is released upon contact with the
chemically modified artificial surface of the biomedical device. We would like to achieve this goal
through the following aims:
Aim 1: Develop analytical methods to measure circulating NO donors in the blood.
Selective analytical methods will be developed to quantify potential circulating NO donors (nitrite,
small and large molecular weight S-nitroso thiols) in the blood.
Aim 2: Modulate concentration of circulating NO reservoirs in the blood. This aim is to
assess the effect of the delivered NO gas on the quantity of individual NO metabolites within
the blood. NO gas will be delivered to pre-conditioned blood via an in vitro membrane oxygenator
setup. This will allow for precise control of the delivery of NO to the blood (partial pressure of NO and
O2, flow rate of sweep gas and blood).
Aim 3: Modify EC surfaces that can induce NO release from circulating NO reservoirs.
We will coat PVC tubing with a polymer coating doped/covalently modified with divalent metal ions
(Cu2+) and assess its ability to induce NO release from the circulating NO reservoirs and to prevent
blood clot formation in vitro in Chandler loop model.

Public health relevance
PROJECT NARRATIVE Thrombus formation is a common cause of failure of cardiovascular devices. Nitric oxide (NO) emitted at the blood contacting surfaces of biomedical devices may prevent blood clot formation and obviate the need for systemic anticoagulation. We will investigate how the concentration of NO releasing molecules in the blood can be increased and released locally at such surfaces. This supplement is requesting funds through the NHLBI Diversity Supplements Program to facilitate the mentored training of the pre-doctoral graduate student, Hannah Naldrett, and supports the work within the scope of the original project.